CeNeuro 2024: C.elegans Topic meeting Neuronal development, aging, synaptic function and behavior

PI: Buelow, Hannes E.
Project Summary
The "CeNeuro2024 C. elegans Topic Meeting: Neuronal Development, Aging, Synaptic Function, and
Behavior" serves as a unique platform for researchers that use C. elegans to address fundamental questions
in neuroscience and neural diseases. C. elegans research has provided critical insights into fundamental and
highly conserved aspects of biology, including neurotransmission, sensory processing, circuit dynamics and
disease. Set to occur biennially at the University of Madison, Wisconsin, this event stands as a cornerstone in
the worm neuroscience community, attracting established leaders, emerging faculty, postdoctoral researchers,
and students from across the globe. Significantly, this conference offers a distinctive arena to (1) Present
leading-edge, unpublished breakthroughs in worm neuroscience; (2) Facilitate verbal and poster presentations
for postdoctoral and graduate scholars, with a special emphasis on women and underrepresented groups; (3)
enable mentorship prospects for new investigators, particularly women and individuals of underrepresented
backgrounds.
Three pivotal themes shape the conference's focus:
Addressing Diversity: The event acknowledges the prevalent scarcity of diversity, particularly gender and
underrepresented groups, within the academic and C. elegans domains. Travel funding will be channeled to
promote the engagement of underrepresented scholars, featuring them as speakers or session chairs, and
fostering diversity and inclusion dialogues with a focus on trainees and junior faculty.
Inclusivity for LMICs: The conference will extend financial support to exceptional trainees and junior faculty
from low- to middle-income countries (LMICs). This initiative seeks to amplify global participation, diversifying
the research realm and nurturing novel cross-cultural collaborations.
Bridging Research Spheres: To bridge the aging and neuroscience research disciplines, the
"CeNeuro2024" conference will synergize the C. elegans Aging & Metabolism and Neuroscience meetings.
Participants of the former will receive stipends, enabling their attendance at a collaborative session on the
inaugural day of the neurobiology meeting, spotlighting aging, metabolism, and neurodegeneration. Beyond
professional ties, joint activities will encourage personal interactions, fostering a holistic integration of aging
and neuroscience research.
In conclusion, funding for this conference endeavors to catalyze gender diversity and involve
underrepresented groups, thereby enriching the research community. It also seeks to embrace trainees and
faculty from LMICs to enhance international collaboration. Lastly, the conference strives to seamlessly merge
the realms of aging and neuroscience research for comprehensive advancements. This initiative holds
potential to redefine the contours of knowledge and propel collective efforts towards innovative scientific
achievements.

Public health relevance
PI: Buelow, Hannes E. Project narrative The C. elegans Topic Meeting: Neuronal Development, Aging, Synaptic Function, and Behavior" is the cornerstone meeting for the worm neuroscience community. To enrich the C. elegans neuroscience research community the meeting will support and promote gender diversity, underrepresented groups and trainees and faculty from low- to middle-income countries. Lastly, to foster interactions between the C. elegans neuroscience and aging and metabolism community we will organize a joint session with the C. elegans Metabolism, Aging, Pathogenesis, and Stress on the first day of the CeNeuro2024 meeting focused on the neurobiology of aging, metabolism and neurodegeneration.